Cell Signaling and Neurodegeneration

DESCRIPTION (provided by applicant): Spinocerebellar ataxia type 1 (SCA1) is one of nine fatal inherited neurodegenerative diseases caused by expansion of an inframe CAG trinucleotide repeat. Each repeat tract encodes a stretch of glutamine residues in the affected protein, in the case of SCA1 the protein is ataxin-1 (ATXN1). Symptoms of SCA1 include loss of motor coordination and balance, slurred speech, swallowing difficulty, spasticity, and some cognitive impairment. A characteristic feature of SCA1 pathology is atrophy and eventual loss of Purkinje cells from the cerebellar cortex. Like many neurodegenerative disorders, SCA1 is typically a late onset disease suggesting that physiological changes due to aging contribute to the onset of the disease. There is currently no effective treatment. Thus, identifying signaling pathways and cellular mediators of SCA1 onset and progression remain a application for continued support. The major aims of this competitive renewal, are: 1) dissecting the signaling pathway(s) and their components that regulate phosphorylation of ATXN1-S776 in cerebellar Purkinje cells in vivo, and 2) assessing whether S776 and its phosphorylation plays a role in mutant ATXN1-induced disease in regions of the brain in addition to Purkinje cells. Most notably the Bulbar signs affecting swallowing, due to pathology in the brainstem

Public health relevance
PUBLIC HEALTH RELEVANCE: We hypothesize that phosphorylation of S776 (residue number based on human ATXN1 with 30Q), is a target for therapeutic development. One aim of this project will undertake a dissection of the ATXN1-S776 phosphorylation signaling pathway in vivo -- not only to better understand the biology of ATXN1 and SCA1 but to also identify additional targets for therapeutic intervention. The second goal will be to examine the extent to which the pS776 pathway contributes to SCA1 in regions of the brain beyond the cerebellum, i.e. does S776 have role in SCA1 phenotypes in addition to the cerebellar ataxia?